The chloride cotransporter NKCC1 in the embryonic etiology and treatment of FASD

ABSTRACT
Preventable as it is by abstinence during pregnancy, maternal ethanol consumption is a significant public health
concern because a significant percentage of pregnant women drink; some even binge drink to risky levels.
Consumption of ethanol during pregnancy can lead to fetal alcohol spectrum disorders (FASD), hallmarked by life-
long neurobehavioral and cognitive abnormalities in the offspring. Indeed, children with history of having been
exposed in utero to even moderate levels of ethanol frequently present with varying degrees of deleterious
neurobehavioral and cognitive outcomes. Yet, effective targeted treatment strategies for FASD/FAS are lacking or ill
defined. The overarching impetus driving this research project is that a better understanding of the cellular and
molecular underpinnings of FASD-associated abnormalities is needed. To this end, we will test a novel mechanistic
hypothesis that ethanol disrupts chloride homeostasis in embryonic neurons, and propose to assess the therapeutic
potential of targeting chloride co-transporters in order to develop and advance strategies for the pharmacological
intervention of FASD in utero.
Specific Aim 1: Test the hypothesis that blocking the function of NKCC1 with its antagonist bumetanide prevents
and/or rescues ethanol’s effect on chloride homoeostasis in migrating embryonic GABAergic cortical interneurons
and mitigates their abnormal tangential migration due to ethanol exposure in utero.
Specific Aim 2: Test the hypothesis that bumetanide treatment prevents and/or rescues the impaired mPFC-
dependent behavioral flexibility and attentional capacity in young adult mice exposed in utero to ethanol.
Specific Aim 3: Test the hypothesis that bumetanide treatment prevents and/or rescues the (1) altered number
and/or distribution of GABAergic cortical interneurons and/or (2) abnormal GABAergic and glutamatergic
neurotransmission in the mPFC of young adult mice exposed in utero to ethanol.
Our previous work established that GABA promotes the tangential migration of GABAergic cortical interneurons,
and that ethanol affects this process to result in an “interneuronopathy” with enduring adverse consequences on
cortical form, synaptic function and neurobehavior. However, the mechanism underlying this interneuronopathy is
not known. The three specific aims will fill this knowledge gap and, in so doing, advance our understanding of the
etiology underlying FASD. Overall, for the first time, NKCC1 will be investigated as a key unifying mechanism
underlying the untoward effects of ethanol exposure in utero on tangential migration, chloride homeostasis and long-
term neurobehavioral and cognitive outcomes, and pharmacologically targeted as potential therapy for FASD. In this
light, this proposal addresses pressing questions in FASD that are highly significant, taking a multi-level
neuroanatomical, electrophysiological and behavioral approach that is innovative, impactful, with great potential for
shedding light on the therapeutic management of FASD.

Public health relevance
Project Narrative Consumption of ethanol during pregnancy can lead to fetal alcohol spectrum disorders (FASD). Despite public outreach and counseling, a significant percentage of women continue to drink during pregnancy, making this a significant public health concern for the wellbeing of the progeny. This concern is exacerbated by the fact that effective FDA-approved targeted treatment strategies for FASD are lacking. We propose experiments that will fill the gap in knowledge between the FASD-associated behavioral abnormalities and its embryonic etiology at the cellular and molecular levels, and to assess the therapeutic potential of targeting chloride co-transporters in order to develop and advance strategies for in utero pharmacological intervention of FASD. Our approach is novel, and the proposal has great translational potential for illuminating mechanism-based management and targeted treatment of FASD.